Administrative Core

PROJECT SUMMARY (See instructions): The Administrafive Core serves all four Projects and the Animal Model Core of the Program Project providing coordinafion, communication services, financial and budgetary services, and other financial and administrative services to the individual Project directors. Coordination between the P.l. and the project directors is maintained and facilitated by administrative personnel. Core personnel arrange regular meefings of invesfigators and distribute pertinent scientific information, progress reports, and internal and external project reviews. Financial services include monitoring the budgets of the individual projects, providing invesfigators with financial information, approving expenditures and providing purchasing assistance, and consolidafion and complefion of progress reports. The Administrative Core also serves as the liaison for the scheduling of yeariy Advisory Committee meetings.

Public health relevance
Inflammatory Bowel Disease afflicts 1.4 million Americans. The Projects in this Program will increase our understanding of theimmune and genefic mechanisms involved in IBD. This Core will provide necessary administrative support and coordinafion forthe Program.